Neural and behavioral trajectories of the overcontrolled phenotype: Associations with development, social context and psychiatric symptoms in early childhood

PROJECT SUMMARY
Heightened performance monitoring and overcontrol (HPM/OC) is a transdiagnostic phenotype comprised of
perfectionism, extreme concern for errors, cognitive inflexibility and excessive need for control. There is
increasing evidence that the HPM/OC phenotype is identifiable in early childhood and underlies obsessive-
compulsive disorder (OCD), social anxiety disorder (SAD) and anorexia nervosa (AN). These psychiatric
disorders are severe, chronic, and treatment-resistant disorders with high rates of comorbidity. However, there
is surprisingly little research examining the neurobiological and behavioral mechanisms that make up the
HPM/OC phenotype in early school-age childhood in relation to the development of transdiagnostic psychiatric
symptoms. Moreover, it is unknown how the HPM/OC phenotype interacts with rapid developmental
progression during this age or is influenced by social-contextual features, such as social evaluation, peer
rejection or parenting styles. Determining answers to these fundamental questions could provide insight into
the emergence of the HPM/OC phenotype and provide novel treatment targets for early intervention. The goal
of the current proposal is to improve understanding of the HPM/OC phenotype in early childhood in relation to
early markers of OCD and SAD by assessing the developmental progression of cognitive facets of
performance monitoring and reactive versus proactive cognitive control and the influence of social-contextual
features on psychiatric outcomes. We posit that cognitive processes that make up the HPM/OC phenotype,
including heightened performance monitoring and more reactive versus proactive cognitive control, interact
with various social contexts to differentiate early school-age children with impairing HPM/OC. The early school-
age period is when HPM/OC is first evident and is a time of rapid cognitive and social development, making it a
pivotal time to understand the developmental psychopathology of this presentation. We will employ cutting-
edge and cost-effective electroencephalogram (EEG) event-related potential (ERP) and time-frequency (TF)
analyses to examine multiple Research Domain Criteria (RDoC) constructs across three repeated yearly
assessments in a sample of 300 community children oversampled for elevated dimensional HPM/OC, ages
spanning 4 - 9 years. This fine-grained evaluation will provide an opportunity to characterize 1) how HPM/OC
impacts normative neurodevelopmental trajectories of RDoC constructs during an age of high neural plasticity,
2) the developmental progression of cognitive facets of the HPM/OC phenotype in relation to transdiagnostic
psychiatric impairment and 3) the impact of social-contextual features that may influence these relationships.
This knowledge could have far-reaching effects on our understanding of the early neurodevelopment of the
HPM/OC phenotype prior to disorder onset, which could inform early identification of high-risk children and
targeted early interventions that could lessen the severity, course and impairment of multiple psychiatric
disorders across the lifespan.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH The proposed study is designed to improve our understanding of the development of neural and behavioral cognitive mechanisms and social processes that comprise the transdiagnostic phenotype of heightened performance monitoring and overcontrol (HPM/OC) in relation to early markers of obsessive-compulsive disorder (OCD) and social anxiety disorder (SAD). Using cutting-edge and cost-effective electroencephalogram (EEG) techniques, we will investigate these relationships using three yearly assessments in a large sample of children spanning 4-9 years of age to assess developmental trajectories of cognitive Research Domain Criteria (RDoC) constructs in the emergence of the HPM/OC phenotype and in relation to relevant social contexts and psychiatric impairment. The overarching goal is a better understanding of the neurodevelopment of the HPM/OC phenotype in order to identify children at highest risk for multiple forms of psychiatric illness and to inform novel interventions that directly target the cognitive and social mechanisms of HPM/OC for optimal early intervention.